Training and Development

Project Summary
The Training and Development (TD) component supports CIRCLE’s main themes of commitment to a multi-
system, multi-disciplinary, and bi-directional approach to translational science between academia and
Indigenous communities. The TD component consists of four primary functions, including providing
opportunities for maternal health research education, support for mentorship, training and transitioning
maternal health researchers to be independent investigators, and developing and nurturing early career
scholars. The primary goal of the TD component is to support the research infrastructure required for
discovering sources of Indigenous maternal health disparities and translating science into solutions to eliminate
those inequities. The TD is responsible for achieving aims two and three of the CIRCLE, which are to: (2)
cultivate and support a multidisciplinary team of independent experts focused on discovering the bases for,
and solutions to, Indigenous maternal health disparities and (3) establish the foundation and initial processes
necessary to enable translational research and interventions focused on eliminating Indigenous maternal
health disparities. These aims will be achieved by accomplishing four specific corresponding aims, each
representing a major function of the TD. These include: 1) Launch an Indigenous maternal health education
and training online toolkit that provides a unified site to disseminate training opportunities, videos and
presentations, tip sheets and curated clinical evidence repository for patients, practitioners, investigators, and
research staff; 2) Ensure comprehensive support for the professional development and mentorship of maternal
heath investigators and practitioners; 3) Prepare early career investigators to be capable and committed to
community-engaged and translational research on Indigenous maternal health; and 4) Locate, support, and
nurture individuals from diverse backgrounds and disciplines to engage in maternal health research. Achieving
these aims is significant because they contribute to the development and sustainability of a research center
focused on Indigenous maternal health equity in the Southern Plains. There are no other research centers in
the U.S. with this focus; consequently, achieving our aims will fill a critical research gap for advancing public
health and clinical care. The TD component is also innovative as it will integrate personnel, resources, and
activities across multiple academic institutions spanning the state of Oklahoma, a comprehensive academic
healthcare system of hospitals, clinics, and centers of excellence, and close partnership with the Southern
Plains Tribal Health Board, the liaison between the National Indian Health Board and the 43 federally
recognized tribes in Kansas, Oklahoma, and Texas, to achieve CIRCLE’s aims.